The Subjective Experience of Diabetes Among Urban Older Adults

DESCRIPTION (provided by applicant): Rates of type 2 diabetes mellitus (T2DM) have grown significantly in the last decade. Older adults, especially older adult ethnic minorities, are exceptionally vulnerable to diabetes and many experience difficulties adhering to self-management recommendations related to diet, exercise, glucose testing and medication. The proposed 36-month study investigates the subjective construction of diabetes among male and female African-American and non-Hispanic white older adults, age e50, with T2DM, living in Baltimore City (n=80). Using the McGill Illness Narrative Interview (MINI), a semi-structured ethnographic interview guide, we will explore participants' perceptions of their diabetes and their understandings of diabetes management. This study takes an innovative approach to diabetes understanding and management as it employs a social constructionist perspective, that is, this study seeks to identify what people themselves think about their diabetes and how local social, cultural, and material contexts inform participants' conceptions of their diabetes and their approach to managing their illness. This study also is unique as the sample will be drawn from NIH's intramural Healthy Aging in Neighborhoods of Diversity across the Lifespan Study (HANDLS), a community-based, fixed- cohort, epidemiological study (n=3722) of cardiovascular and cerebrovascular disease risk in Baltimore. By obtaining our sample from the community-based HANDLS study we will be able to capture persons who normally may not be included in a clinic-based study, i.e., persons not seeking treatment for their diabetes. We will employ code-based and case-based analytic strategies in order to examine how diabetes understandings, management, and social contexts vary across and within race and gender categories, and with respect to diabetes duration and control. We argue that greater understanding of this subjective experience of diabetes is needed in order to more effectively help patients to negotiate the beliefs and contexts that play a role in self-management.

Public health relevance
Public Health Relevance The prevalence of diabetes continues to increase at epidemic proportions while adherence to self-management programs remains challenging, especially for older adults in urban contexts. This study of older adults' subjective understandings of their diabetes will provide rich, detailed insight to the construction of diabetes and diabetes management among older adult urban residents, and the ethnic and gender variation in these constructions. This study will offer health care providers a better understanding of the ways in which subjective beliefs and experiences must be taken into account when working conjointly with patients to develop self- management plans. __SpecificAimsTextDelimiter__ Specific Aims Rates of type 2 diabetes mellitus (T2DM) have grown significantly in the last decade, with high prevalence rates particularly common among older adults and minorities.1, 2 Self- management is often promoted as a key to mitigating the effects of diabetes, but adherence to self-management recommendations can be difficult for patients, and providers often are limited in their ability to facilitate patient self-management.2 We argue that the subjective construction and definition of diabetes and its management must be examined to more effectively address the diabetes epidemic. [By identifying what people themselves think about their illness and its management we can help providers to better attend to the self-management concerns and constraints facing African-American and non-Hispanic white older adults within urban settings.] The proposed 36-month study investigates the subjective construction of diabetes among African-American and non-Hispanic white older adults, age e50, with T2DM, living in Baltimore City (n=80). We will use the McGill Illness Narrative Interview (MINI), a semi-structured ethnographic interview guide that we have modified for this study.3 We seek to identify how local social, cultural, and material contexts inform participants' conceptions of their diabetes, perceptions of its risk factors and comorbidities, and their approach to managing their illness. This study involves a unique partnership with the NIA Intramural Healthy Aging in Neighborhoods of Diversity across the Lifespan Study (HANDLS), a community-based, epidemiological study of cardiovascular and cerebrovascular disease risk in Baltimore (n=3722). Initiated in 2004, HANDLS is a 20-year, prospective, fixed-cohort study with interview waves occurring at least every 3 years. At baseline, the prevalence of T2DM in HANDLS' sample was 17% (Zonderman, personal communication, 4/28/11). While the HANDLS staff informed participants about their diabetes diagnosis, HANDLS provides no diabetes intervention or treatment and is not investigating participants' diabetes knowledge or management. By drawing our sample from HANDLS, we will have a community-based sample of persons with clinically diagnosed diabetes. As a community-based rather than clinic sample, our sample is not limited to persons who are predisposed to or able to access a biomedical clinic or intervention. Our sample will include adults who were diagnosed with diabetes and responded with whatever action they deemed fit, including no action. The proposed research has four specific aims: 1. Identify participants' subjective accounts of their diabetes, including perceptions of the etiology, risk factors, symptoms, secondary conditions, and short and long term outcomes of their diabetes 2. Elicit participants' diabetes management practices, including perceptions and use of biomedical and lay (popular or folk) health care resources and self-management activities 3. Explore participants' accounts of the social context within which their diabetes is embedded, including how participants manage their diabetes with respect to other responsibilities and constraints, such as family care taking, job constraints, transportation, finances, time commitments, or other illnesses 4. Determine the race and gender variations in participants' subjective understanding of their diabetes, their diabetes management strategies, if any, and the social contexts surrounding their diabetes Together, addressing these specific aims will provide rich, detailed insight into the subjective definition and construction of diabetes and diabetes management among urban older adults, and the race and gender variation in these constructions. [We believe these aims will offer providers a better understanding of the subjective arenas in patients' lives that must be taken into account when working conjointly with patients to develop self-management plans.]